RADXHIV VIRAL LOAD

ABSTRACT
The Johns Hopkins Center for Innovative Diagnostics for Infectious Diseases (JH-CIDID) aims to accelerate
the development of point-of-care HIV viral load in vitro devices using the Rapid Acceleration of Diagnostics
Technology (RADx Tech) model. We are requesting some supplemental funds to cover time for staff and
faculty salaries needed for the extended time period and tailored work scope for each HIV point-of-care viral
load platform to be evaluated. This cost extension will support three HIV point-of-care viral load assays where
individualized assessments were collaboratively developed with the companies that are appropriate for their
stage of development and tailored to their platforms to accelerate the attainment of critical milestones to derisk
these promising assays. Differences in the technical approach and platform maturity required more
individualized work plans and IRB amendments than was originally anticipated. In vitro devices are
independently evaluated by JH-CIDID through benchtop evaluations to test diagnostic performance with
blinded panels for performance, userability, hands-on time, and turnaround time. Key technical challenges are
communicated to developers through written feedback. Those with acceptable benchtop performance will
undergo prospective pre-clinical testing with fresh blood and iteratively improve to accelerate development and
derisk expensive clinical trials for regulatory approval. The HIV epidemic is now in its 4th decade. The critical
role of diagnostics in identifying people living with HIV and linking them to treatment or prevention has been
highlighted by the United Nations Programme on HIV/AIDS. Our group is ideally placed to leverage existing
infrastructure and expertise in clinical point-of-care diagnostic evaluation, deep HIV clinical and laboratory
expertise, and a variety of accredited labs for gold-standard testing.

Public health relevance
NARRATIVE Point-of Care HIV viral load tests to rapidly and accurately diagnose HIV will be tested and iteratively improved. Development of tests that can rapidly diagnose HIV or treatment failure will prevent the spread of HIV; these tests can also be used to identify individuals who can benefit from preventative treatment.